Administrative Core

ADMINISTRATIVE CORE: PROJECT SUMMARY/ABSTRACT
The mission of the Columbia University George M. O’Brien Urology Cooperative Research Center is to
advance the understanding of benign genitourinary diseases/disorders. The Center consists of an
Administrative (Admin) Core, a Microbial Genomics Biomedical Research Core, and three Research
Projects that include preclinical and clinical studies. Our focus includes: (1) the intersection of the host
genome and the urinary microbiome; (2) the transcriptional regulation of urothelial differentiation during
homeostasis and repair in response to UTI; and (3) how the regulation of urinary chemistry and urothelial
iron metabolism (“iron-heme machine”) is a component of the urothelial response to UTI. We anticipate
that the proposed studies will provide new insight into the pathogenesis of disorders of high relevance to
benign urology and also facilitate introduction of genetic testing into the practice of Urology and even
suggest new treatments. We will examine the interactions between host and invading bacteria, and the
role of nutrient iron in shaping the outcome of UT infections; we will undertake a new GWAS analysis to
search for mutations that lead to LUTD, including incontinence, obstruction and pelvic floor prolapse, we
will analyze the urinary microbiome of patients with lower urinary tract disfunction (LUTD), and we propose
to identify pathways that program urothelial cell types that may be used to treat benign urothelial
abnormalities associated with disease. The most important goal of this center is to utilize the expertise and
experience of the urological community to increase the scope of our studies and to help direct the kinds of
questions we will address. We have directly integrated members of the P20/U54 community as well as
clinicians and scientists in the benign urological community. Co-investigators on our projects include Indira
Mysorekar (P20), an expert in UTI and urothelial biology who will work with Dr. Mendelsohn and Dr.
Barasch, Chad Vezina (Wisconsin U54) and collaborating scientists and clinicians from the benign
urological community, (Lori Birder, Gerry Apodaca, Doug Strand). In addition, we have invited outside
experts to join our work, for example, the heme biologist, Iqbal Hamza (University of Maryland). We are
also highly focused on education and outreach: Our summer program has trained 73 students since our
center has been established, including undergraduates, fourth year medical students and urology
residents. we have provided opportunity pool funds to Dr. Putonti (Loyola University) and Dr. Catherine
Brownstein, (Harvard University). We held a Symposium in October of 2019 that was extremely successful
"The problem of UTI: The microbiome of the Urogenital Tract and its immune Defense" bringing together
a dozen experts with >138 members of the Urological community.